ADVANCED TECHNOLOGY QA CENTER

It is well recognized that there are several programs within the United States that are capable of developing Quality Assurance programs for advanced technologies in radiation therapy. The goal of this application is to capitalize on the infrastructure and strengths of several Quality Assurance programs to develop a superstructure capable of developing Quality Assurance programs for advanced radiation technologies. The goal of this endeavor is to utilize the strengths of these defined programs in developing uniformity in quality assurance in advanced technologies throughout all participating Cooperative Groups. Specifically we propose to (1) develop quality assurance programs in three-dimensional conformal therapy that will be uniform to all Cooperative Groups who choose to participate in this program; (2) develop equivalent programs in brachytherapy to multiple body part sites to ensure uniformity and quality assurance and establish standards in normal tissue tolerance; (3) establish uniform guidelines in database interpretation that allow for all dose-volume histogram analysis for tumor volume and normal tissue to be housed in one database. We will also establish a program to house data in both tumor volume coverage and normal tissue coverage to enhance our knowledge about outcome analysis; (4) To provide appropriate storage and interpretation of diagnostic x-rays required for protocol analysis; (5) develop QA programs for further advanced technology treatment programs such as Intensity Modulated Radiation Therapy.